Administrative Core

Abstract. The goal the Emory Roybal Center for Dementia Caregiving Mastery is to identify, support, and
advance behavioral intervention programs that effectively address caregiving challenges across a broad range
of heterogeneous caregiving contexts and to strengthen informal caregiving mastery within these contexts.
The Administrative Core will play three key roles. It will play a development role in implementing and
managing structures and processes that ensure an ample flow of clinical trial intervention proposals grounded
in genuine participatory dialogue with caregiver and care recipient consumers, the effective selection support,
oversight, and stage advancement of tested interventions, and the advancement of the science of intervention
development. The Core will coordinate the activities of interest-generation structures, including a monthly
Caregiver Research Interest Group conversation among caregiver researchers, the development of context/
situation-focused webinars, and the maintenance of the Center’s website that will be pivotal in stimulating pilot
ideas and drawing interest to the Center’s theme of the heterogeneity of caregiving. The Core will be the nexus
for all of these linkages. The Center will maintain our collaborations with the Rochester and OHSU AD Roybal
Centers and seek to develop collaborations with new AD Roybal Centers. The Core will also be responsible for
continuing to build on the leadership team’s linkages with the NIA Alzheimer’s Disease Centers and IMPACT
Collaboratory and the VA Geriatric Research, Education, and Clinical Centers and other national centers to
stimulate ideas and attract potential clinical trial investigators to the Center. The Core will play a management
role. Supported by the pre- and post-award capabilities of Emory’s Nursing and Public Health Research
Administration Service, the Core will assume the central management role in the Center, providing
administrative and financial oversight to the Behavioral Intervention Development Core and the Center’s
behavioral intervention clinical trial projects to enable trial investigators to advance successful interventions to
their next stage of development. It will coordinate the activities of the Stakeholder, External, and Local Advisory
Boards and it will be responsible for the scheduling, conduct, and documentation of the variety of meetings,
including an Annual Meeting, meant to keep the Center and the supported trials on track. In this role, the
Administrative Core will also provide linkage and coordination with the National Institute on Aging and with the
Roybal Coordinating Center, ensuring timely reports, collaboration, and participation in Roybal Center national
meetings. The Administrative Core will play a key role in activities designed to promote the sustainability of the
Center. It will be responsible for the conduct and analysis of the Center’s evaluation plan and for taking any
steps identified by the evaluation to advance Center success. Finally, the Administrative Core will drive Center
dissemination activities, organizing pre-conference workshops at national meetings, and promoting reports of
clinical trial findings, all aimed at the advancement of the science of intervention development.